Cardiomyogenesis in the Adult Heart

DESCRIPTION (provided by applicant): An important issue in need of resolution concerns whether myocyte regeneration in the adult heart is controlled exclusively by activation and commitment of resident c-kit-positive cardiac stem cells (CSCs), or circulating hematopoietic stem cells (HSCs) from the bone marrow contribute to cardiomyogenesis. Although CSCs divide asymmetrically being able to self-renew and form a specialized progeny, whether this stem cell compartment is fully independent from the pool of HSCs in regulating cardiac homeostasis remains controversial. In an attempt to resolve this biological problem, bone marrow transplantation and a model of parabiosis will be employed to establish quantitatively the relative role of HSCs and CSCs in myocyte renewal in adulthood and in tissue regeneration following ischemic myocardial injury. An additional complementary question is whether stem cells in the niches are all of cardiac origin or HSCs migrate from the bone marrow to the myocardial niches where they attain a new identity participating in the turnover of these primitive cells in their microenvironment. If this were the case, HSCs would be involved in the preservation of the stem cell pool in the heart, which constitutes the growth reserve of the myocardium throughout the course of life. A common mechanism involving oscillations in intracellular Ca2+, cell cycle entry, asymmetric division, and nuclear shuttling of the myocyte transcription factor Nkx2.5 is postulated to regulate the lineage specification of CSCs and HSCs into cardiomyocytes. Ultimately, the molecular mechanisms of HSC transdifferentiation will be identified and the involvement of the bone marrow in cardiomyogenesis carefully defined. PUBLIC HEALTH RELEVANCE: This research aims at the identification and quantification of the celular proceses that regulate cardiac homeostasis and myocardial regeneration following ischemic injury. Both CSCs and HSCs are postulated to contribute to myocyte regeneration physiologically and after myocardial infarction. If successful, novel strategies for the treatment f the diseased heart may be identified.

Public health relevance
This research aims at the identification and quantification of the celular proceses that regulate cardiac homeostasis and myocardial regeneration following ischemic injury. Both CSCs and HSCs are postulated to contribute to myocyte regeneration physiologically and after myocardial infarction. If successful, novel strategies for the treatment f the diseased heart may be identified.